Proteomic Core D

Abstract
Complex biological processes like auditory neural aging are composed of dynamic changes in individual neurons'
biochemistry, with various aging process susceptibilities. Direct measures of a single auditory neuron (spiral
ganglion neuron (SGN) and cochlear nuclei (CN) neuron subtypes) and their age-related alterations are needed
to characterize cellular transitions, regulatory mechanisms, and the microenvironment's contribution to age-
related hearing loss (ARHL). A critical unmet need is determining the biochemical makeup of healthy and aged
SGNs with single-cell resolution and a depth of coverage extending to thousands of biomolecules. Proteins
mediate the bulk of cellular function, and the correlation between RNA and protein abundance is often lacking,
and the proteome largely determines cellular structure and function. We hypothesize that the aging SGN
undergoes a profound proteomic dynamic that is neuron subtype-specific.
The aims of Core D are:
1. To refine liquid chromatograph-mass spectrometry (LC-MS)-based proteomics platform for sensitive and
high-throughput SGN proteomics.
2. To apply the improved platform to study aging-related proteome regulations for SGN and CN subtypes and
at single-cell resolution.
The proposed effort will result in a processing and analysis platform capable of direct and unbiased profiling of
SGNs and CN neurons with a depth of coverage of >3000 proteins/cell, thus providing a capability for direct
protein measurement analogous to single-cell RNA-seq. Core D serves as a resource to identify ARHL
biomarkers for Projects 1-3 to test and perform functional analyses. Outcomes will produce unbiased and in-
depth single-cell protein profiles of SGNs and CN to provide a complete picture and identify protein biomarkers
associated with ARHL.

Public health relevance
Project Narrative Proteins mediate the bulk of cellular functions. Here, we will use innovative strategies to determine the up and down-regulated proteins in aging auditory neurons.